ChREBP in Liver Metabolism: Defining Mechanisms and Resolving Controversies

This project investigates the role of Carbohydrate Responsive Element Binding Protein (ChREBP), a
key transcription factor in metabolic regulation and disease, particularly focusing on its isoforms and their
effects in the liver. ChREBP has been implicated in metabolic-associated steatohepatitis (MASLD),
dyslipidemia, and cardiometabolic diseases, yet the specific functions of its isoforms remain controversial and
poorly understood, in part due to conflicting reports published in a variety of gain- and loss-of-function ChREBP
mouse models. In this project we aim to resolve the contradictory roles of ChREBP isoforms in liver
metabolism, thereby enhancing our understanding of metabolic disease mechanisms. This will serve our long-
term objectives of providing foundational principles of liver metabolism that may ultimately lead to improved
diagnostic and therapeutic strategies for metabolic disorders including dyslipidemia, diabetes, and MASLD.
The study employs genetic interventions (knockouts and overexpression) in mouse models and molecular
phenotyping to dissect the metabolic pathways and molecular physiology influenced by ChREBP isoforms.
Techniques include GalNAc-siRNA-mediated knockdown, ADV-mediated overexpression, and AAV-TBG-
Crispr modifications in mouse models. This approach will enable a detailed analysis of the physiological
impacts of ChREBP under various metabolic contexts, offering insights into its dual roles in metabolic
diseases. In Aim 1, we aim to define the role of hepatic ChREBP-beta in a model where ChREBP-alpha has
been ablated, testing if modest increases in its expression are sufficient to adversely affect liver and systemic
metabolism. In Aim 2, we will explore dose-dependent effects of ChREBP overexpression on liver function and
systemic metabolism, focusing on glucose homeostasis and mitochondrial dysfunction. Aim 3 investigates the
activation of ChREBP by specific carbohydrate metabolites under different dietary conditions, employing Crispr
strategies to modify key enzymes in metabolite pathways that may provide metabolites that activate ChREBP.

Public health relevance
This research project focuses on understanding the role of a protein called ChREBP, which is crucial in managing how our body responds to sugars. ChREBP's activity is linked to liver health and could either protect against or contribute to serious conditions like liver disease, diabetes, and heart-related disorders, depending on its behavior in different situations. By clarifying how ChREBP works, this study aims to improve how we diagnose and treat metabolic diseases, potentially leading to better health outcomes for people with diabetes and other related conditions.